Life in slow motion: smart multimodal imaging at kilohertz rates

PROJECT SUMMARY
This project aims to develop new scalable nD cellular and unicellular organism imaging and analysis approaches
to study the ‘rules of life.’ We propose to develop a novel multimodal imaging platform, blending fluorescence
super-resolution and tomographic polarized light imaging. Paired with the proposed platform, we will provide an
open-source suite of computational imaging tools to recover the dielectric tensor in multiple scattering samples
using GPU acceleration. As part of these tools, we address optimal pattern generation, correct for phase drift,
test against rigorous simulations, and integrate recent advancement in deep learning denoisers. We will
benchmark the platform’s performance on two cellular motility projects. In the first project (Aim 2), we will quantify
both 3D hydrodynamic flow fields surrounding motile bacteria using tomographic polarized light imaging and
molecular cell fate markers using fluorescence. We then aim to demonstrate two unique measurements by
quantifying the flow field and cell fate of motile bacteria near or at surfaces and near the edge of a swarming
bacteria colony. In the second project (Aim 3), we will quantify for the first time the local 3D viscoelastic properties
and applied forces for eukaryotic cells placed into collagen matrices. We will validate our measurements using
known atomic force microscopy and standard 2D traction force measurements before attempting to generate
self-calibrated 3D traction force microscopy data by quantifying the local viscoelastic environment surrounding
the motile cells. Across all three aims, we intend to demonstrate a multimodal imaging platform that is easily
adaptable and addresses critical needs as the community moves towards probing biology at the fastest rates
possible.

Public health relevance
Project narrative Understanding how cells navigate their local environment is critical to understanding the 'rules of life.' Here, we propose to develop a new multimodal optical microscopy platform to simultaneously quantify the movement of cells, the physics of the local environment, and proteins known to correlate with cell fate. The proposed method aims to improve the state of the art in nD microscopy by generating fluorescence super-resolution and 3D polarized light images at rates up to 1 kHz.